Suvorexant: A Dual Orexin Receptor Antagonist for Treating Sleep Disturbance inPosttraumatic Stress

Posttraumatic stress disorder (PTSD) is a common consequence of combat that is manifested in part by
trauma-related hyperarousal and reactivity, seen in increased startle responses and impaired sleep that result
from central and autonomic nervous system alterations. In fact, disturbed sleep is the most prevalent symptom
endorsed by PTSD patients and is potentially debilitating in many domains of functioning (1, 2). As a relatively
non-stigmatizing symptom, it is no surprise that disturbed sleep is often the reason that motivates Veterans
with PTSD to seek treatment (3, 4). However, most drugs that target sleep result in unwanted side effects,
such as next day somnolence, which can impact functioning in both military and civilian life. Furthermore, aside
from several SSRI's that are only moderately effective in improving PTSD, little progress has been made
toward advancing pharmacological treatments for PTSD and in Veterans.
Preclinical evidence suggests that the orexin neuropeptide system may be a shared mechanism accounting for
both sleep disturbance and PTSD. Orexin is a central promoter of wakefulness involved in regulation of sleep,
and in fear learning and emotional memory. The dual orexin receptor antagonist, suvorexant, is the first of a
new class of medications recently FDA-approved to treat insomnia. In contrast to previous generations of
treatments used for patients with PTSD that provide delayed and often inadequate symptom relief, suvorexant
holds promise of delivering immediate relief for pressing sleep concerns while also potentially reducing PTSD
symptoms by targeting a biological mechanism that may account for both conditions. While its efficacy for
insomnia has been strongly supported by clinical trials (5-8), the potential benefit of suvorexant on trauma-
related sleep disturbance and on PTSD symptoms has not been examined, nor has it been evaluated for
safety and tolerability in Veterans.
We propose a two-site parallel group, randomized, double-blind, placebo-controlled Phase IV clinical trial to
test the efficacy and safety of suvorexant on trauma-related sleep disturbance and PTSD symptoms in
Veterans. We will use a flexible dose design of suvorexant with a 2-week titration followed by a 10-week
steady-dose phase. We predict that suvorexant, as compared to placebo, will result in a greater decrease in
insomnia on the Insomnia Severity Index (ISI) over the 12-week trial. We also predict that suvorexant, as
compared to placebo, will result in a greater reduction in non-sleep PTSD symptoms in the Clinician
Administered PTSD Scale for DSMV (CAPS-5) over the 12-week trial. Secondarily, we will examine potential
objectively measured wrist actigraphy as a biological mechanism of clinical improvement with as well as
concomitant effects on PTSD-related nightmares using the Pittsburgh Sleep Quality Index-PTSD addendum
(PSQI-A). Pending a significant effect of suvorexant on PTSD, we will perform exploratory analyses to evaluate
whether sleep improvement mediates the effect of suvorexant on PTSD symptoms. We will also examine
safety and tolerability of suvorexant compared to placebo (including depression, mood, vigor, suicidality, and
daytime somnolence, psychomotor vigilance, and functional disability). Results from this study will provide
substantive rationale for the use of Suvorexant in the treatment of Veterans with these concerns. This study
will be the first to examine a selective orexin-receptor antagonist in a Veteran sample with PTSD. Suvorexant
is an accessible, non-stigmatized medication whose use and safety has been well-established in non-mental-
health settings. It has outstanding promise for treating common and distressing symptoms in Veterans as well
as civilians with trauma-related sleep disturbance and PTSD.

Public health relevance
Post-traumatic stress disorder (PTSD) is a common consequence of combat that can result in trauma-related hyperarousal and sleep disturbances. Poor sleep, one of the most common complaints in Veterans with PTSD, can be distressing, impair concentration and memory, and contribute to physical health conditions, such as metabolic syndrome, inflammation, and cardiovascular disease. The orexin neuropeptide system underlies both sleep and stress reactivity. Suvorexant, a drug that reduces orexin, improves sleep in civilians, but has not yet been tested in Veterans with PTSD. This study will test whether suvorexant can improve sleep disturbances and PTSD symptoms in Veterans. Suvorexant may benefit Veterans by improving sleep quickly while also reducing PTSD symptoms over the long term, and with fewer side effects that were common in previous medications used to treat these conditions. Improving Veterans' sleep and PTSD symptoms could lead to better emotional and physical well-being, quality of life, relationships, and functioning.